Training Clinical Scientists in Radiological Imaging

The UCSD Department of Radiology is submitting a competitive renewal of its postdoctoral Clinician-Scientist
Radiology Residency Program (CSRRP). The objective of the program is to train clinician-scientists in imaging
research, promote their career development, and cultivate their passion for academics. This program is necessary
because the continued advancement of imaging science requires the training and career growth of dedicated researchers
to develop, refine, and translate innovative imaging methods to diagnose and treat disease. To support and nurture these
trainees, we have capitalized on our rich institutional resources to implement a unique Residency Program that
integrates rigorous research, intense clinical education. and strong and sustained mentorship. Into this program, we
admit three highly selected radiology residents per year. All our trainees are MDs or DOs, and most have dual degrees.
The trainees dedicate their entire first year to laboratory research, followed by 6 weeks of protected research time per
year during each of the subsequent 4 years of clinical training. The clinical years are consecutive to maximize the
trainees' clinical education. The additional 6 weeks per year of research allows them to maintain interactions with their
research laboratory, tackle high-risk/high-gain projects rather than choose short-term endeavors with one-year horizons,
move their chosen research projects forward toward fruition, publish results, and gain grant support. In consultation with
the program co-Directors, each trainee selects at least two mentors: a lab mentor who provides supervision in research
and a mid- or senior-level academician who provides guidance in general career development. Together, the research
and career development mentors help the resident design a career path with high likelihood for future success in
academic radiology. For this proposal, we have assembled 22 Radiology and 9 non-Radiology research mentors with an
average grant support of nearly $800,000 per faculty member. Scientific areas span the translational spectrum and
include molecular imaging and contrast media, novel MR pulse programming, quantitative imaging analysis, and
imaging biomarker validation. Supplementing these robust career mentorship relationships are numerous opportunities
to promote resident education and engagement. Regular monthly lectures and workshops are given by notable experts in
topics relevant to the research residents, such as academic career development, success in research, and responsible
conduct of research. Participation in scientific conferences, departmental Grand Rounds, and other meetings offer
opportunities for residents to share their work through formal presentations. A grant writing course helps trainees learn
to develop strong, clear proposals. Mid-training and senior CSRRP residents learn leadership and administrative skills
through the Outreach Leader opportunity and the Chief Residency year, respectively. Empowering the trainees to serve
as Chief Residents facilitates trainee feedback and helps ensure the program supports the trainees' needs. Our graduates
emerge with strong foundations in research and clinical radiology, positioned to become successful clinician-scientists
with the potential to shape and drive the continued advancement of our field.

Public health relevance
PROJECT NARRATIVE The UCSD Dept. of Radiology is resubmitting a competitive renewal of its postdoctoral training program to develop clinician-scientists in radiology through a full year of laboratory research followed by 6 weeks of protected research time during each of their subsequent 4 years of clinical training. Trainees will be supported by 31 outstanding mentors that together have 46 active grants totaling nearly $25M.